Investigate the Transcriptional Co-factors of DAF-16/FOXO in C. elegans

Project Summary: Transcription factors of the DAF-16/FOXO family are evolutionarily conserved master regulators capable of integrating diverse environmental stimuli and coordinating development, metabolism, stress responses, and longevity. Deregulation of FOXO proteins in humans is well known to play a key role in age- related diseases such as cancer and diabetes. For DAF-16/FOXOs to achieve their multi-faceted and central roles, their transcriptional activities need to be exquisitely regulated; however, the mechanisms underlying the regulation of DAF-16/FOXO-mediated gene transcription are largely unknown. The long-term goal of this proposal is to elucidate comprehensively how DAF-16/FOXO transcriptional activities are regulated in the nucleus and how this regulation contributes to longevity determination. We recently discovered that the C. elegans ortholog of the nuclear protein host cell factor 1 (HCF-1) modulates longevity by functioning as a DAF-16 co-factor that inhibits DAF-16-mediated gene regulation. Since HCF-1 is the first DAF-16 negative co-factor reported in C. elegans, this finding provides an important entry point for further investigation of how DAF-16 transcriptional activities are regulated. In Aim 1, we propose to test the hypothesis that the specificity of DAF-16-mediated transcriptional output is determined by the interplay between HCF-1 and other DAF-16 co-factors. In Aim 2, we propose to test the hypothesis that HCF-1 forms a regulatory network with SIR-2.1 to regulate DAF-16 transcriptional activity on specific target genes. In Aim 3, we propose to identify additional transcription and chromatin factors that regulate DAF-16-mediated gene transcription. Since DAF-16 and its co-factors (HCF-1, SIR-2.1, SMK-1, BAR-1, CTBP-1) are all highly conserved, findings from our studies will provide important insights into FOXO regulation and longevity determination in mammals. Moreover, the mammalian orthologs of DAF-16 and its co-factors are known to play key roles in the pathogenesis of a number of human diseases, such as cancer and diabetes, findings from our studies may inspire future therapeutic development aiming to alleviate some of these age-related pathologies in humans.

Public health relevance
Project Narrative: Transcription factors of the DAF-16/FOXO family are highly conserved master regulators capable of integrating diverse environmental stimuli and coordinating development, metabolism, stress responses, and longevity. This application proposes to use the powerful genetic model C. elegans to investigate how several highly conserved DAF-16 co-factors function together to precisely control DAF-16-mediated gene regulation. The findings from this proposal will have direct relevance to FOXO regulation in mammals and will provide important insights into the biology of aging, and may inspire future therapeutic development that aims to benefit longevity and alleviate age-related diseases. __SpecificAimsTextDelimiter__ 5.5.2 Specific Aims Transcription factors of the DAF-16/FOXO family are critical, evolutionarily conserved longevity determinants [5-7]. Although DAF-16/FOXO proteins are best known as the major downstream effectors of insulin/IGF-1 signaling (IIS), it is becoming increasingly clear that they have broader roles as master regulators capable of integrating diverse environmental stimuli and coordinating development, metabolism, and stress responses in addition to longevity [8]. For DAF-16/FOXOs to achieve their multi-faceted and central roles, their transcriptional activities must be exquisitely regulated; however, the mechanisms underlying the regulation of DAF-16/FOXO-mediated gene transcription are largely unknown. The long-term goal of this proposal is to elucidate comprehensively how DAF-16/FOXO transcriptional activities are regulated in the nucleus and how this regulation contributes to longevity determination. Our studies will be aided by operational advantages of the C. elegans system and are motivated in large part by novel findings from our laboratory during the previous funding period [1]. C. elegans has only one DAF-16, whereas mammals have four FOXO homologs; this simplification in combination with the wealth of resources available for aging investigation in C. elegans provide a particularly powerful model for the mechanistic dissection of DAF-16/FOXO regulation and its contributions to longevity determination. Moreover, we recently discovered that the C. elegans ortholog of the nuclear factor host cell factor 1 (HCF-1) modulates longevity by functioning as a DAF-16 co-factor that inhibits DAF-16-mediated gene regulation [1]. Since HCF-1 is the first negative co-factor of DAF-16 reported in C. elegans, this finding provides an important entry point for further investigation of how DAF-16 transcriptional activities are regulated. The overall hypothesis of this application is that the interplay among the various DAF-16 co-factors determines DAF-16-mediated transcriptional outputs and longevity. Considering that DAF-16 and its co-factors are highly conserved, a thorough elucidation of the molecular control of DAF-16 transcriptional activities in C. elegans will provide critical mechanistic insights into longevity modulation in diverse organisms, and will have important implications for future therapeutic development aiming to alleviate aging-related pathologies in humans. We propose the following specific aims: Aim 1: Test the hypothesis that the specificity of DAF-16-mediated transcriptional outputs is determined by the interplay between HCF-1 and other DAF-16 co-factors. In addition to HCF-1, several other putative DAF-16 transcriptional co-factors have been reported (SIR-2.1, SMK-1, BAR-1, CTBP-1) [9-12]. Nothing is known about how the different DAF-16 co-factors inter-connect with each other. We propose to use genetic interaction experiments to determine whether they genetically interact with each other to affect longevity and stress responses in C. elegans. We will also use expression profiling experiments to determine whether the various DAF-16 co-factors regulate the expression of overlapping or distinct subsets of DAF-16 transcriptional targets. Aim 2: Test the hypothesis that HCF-1 forms a regulatory network with SIR-2.1 to regulate DAF-16 transcriptional activity on specific target genes. Our preliminary results indicate that hcf-1 and sir-2.1 both act upstream of daf-16 to affect longevity and stress responses, that HCF-1 and SIR-2.1 regulate a largely common set of DAF-16 target genes, and that HCF-1 physically associates with SIR-2.1 and DAF-16 in worms. We propose a series of biochemical and molecular experiments that aim to further elucidate the mechanistic details of the functional interactions between HCF-1, SIR-2.1, and DAF-16. We will investigate the molecular nature of the protein complexes involving HCF-1, SIR-2.1, and DAF-16; we will also examine how HCF-1 may interfere with the localization and action of SIR-2.1 and DAF-16 at the promoters of specific target genes. Aim 3: Identify additional transcription and chromatin factors that regulate DAF-16-mediated gene transcription. Thus far, five DAF-16 co-factors (HCF-1, SIR-2.1, SMK-1, BAR-1, CTBP-1) have been reported. Considering that DAF-16 participates in diverse biological processes, it is very likely that DAF-16 transcriptional activities are regulated by many more nuclear factors than are currently known. We propose to further characterize two new longevity factors we have identified that are predicted to be chromatin modifiers (SET-9, SET-26) and determine whether they affect lifespan by regulating the local chromatin environment of some DAF-16 target genes. Furthermore, we have devised an efficient screen to comprehensively identify the transcription and chromatin factors that affect DAF-16-mediated gene regulation in C. elegans.